Biomaterials-based Immunoengineering for Periprosthetic Joint Infection

Project Summary / Abstract
Due to advances in biomedical engineering and medicine, joint replacement has restored function
and relieved pain for millions of people. However, subsequent infection of implanted joints (known as
periprosthetic joint infection or PJI) is a debilitating condition that can lead to multiple surgeries, long courses of
intravenous antibiotics, and/or loss of limb or even life. Staphylococcus aureus is one of the most common and
virulent organisms that causes PJI. S. aureus is also associated with significant morbidity and frequent relapse
following treatment. Vaccination against S. aureus is a promising strategy to prevent periprosthetic joint
infection. However, traditional vaccine systems designed to prevent S. aureus infection have failed in clinical
trials. The goal of this proposal is to evaluate a novel approach to immunotherapy for S. aureus PJI by
engineering a biomaterials-based vaccine platform (BiVAX). BiVAX is an injectable biodegradable scaffold that
elutes cytokines to recruit dendritic cells, contains adjuvant for activation, and is loaded with antigen at high
concentration for uptake by recruited cells. Our group has previously demonstrated that by using pathogen-
associated molecular patterns as antigen in this biomaterials-based vaccine system, BiVAX is effective against
preventing S. aureus abscesses and lethality from sepsis due to different gram-negative species in mouse
models. PJI is a challenging biofilm-associated device infection, and it is unknown if vaccination can prevent
disease. In this proposal, I will evaluate the effects of infection and vaccination on the host immune response
and determine the efficacy of BiVAX for preventing PJI in murine and rabbit models of disease. I will determine
host immune responses to PJI as a function of immunity and pathogen virulence factors in Aim 1 and evaluate
the effect of BiVAX against PJI and compare its efficacy to conventional vaccination strategies in Aim 2.
I am supported in these efforts by world experts in immunotherapy, vaccine science, and PJI including:
primary mentor David Mooney (immunoengineering); co-mentor Ruanne Barnabas (vaccine science),
collaborator David Scadden (stem cell biology/immunology); collaborator Jean Lee (murine S. aureus
vaccination); collaborator Michael Super (immunology and glycobiology); advisor Antonia Chen (arthroplasty and
human clinical trials for S. aureus vaccines); advisor Sandra Nelson (clinical periprosthetic joint infection); and
advisor Hang Lee (biostatistics). The resource-rich ecosystem of Massachusetts General Hospital, Harvard
University, and the Wyss Institute for Biologically Inspired Engineering have afforded me the necessary tools to
conduct this multidisciplinary work at the interface of bioengineering, microbiology, and immunology. This
proposal includes a robust training plan designed with my mentors to acquire additional skills in
immunoengineering and vaccine science necessary for launching an independent career investigating
immunity at the host/device/pathogen interface in device-related infection.

Public health relevance
Project Narrative Patients who have received joint replacement are at risk for periprosthetic joint infection, a serious condition which can lead to morbidity, disability, amputation, and even death. We will investigate how an injectable biomaterials-based vaccine system improves host immunity to prevent Staphylococcus aureus periprosthetic joint infection in murine and rabbit models. This project will lead to a better understanding of immunity in device- related infection and characterize a new vaccine modality.